The COVID-19 and Cancer Consortium (CCC19) Registry

Project Summary
People with cancer have a higher risk of infections in general because of vulnerabilities arising
from their cancer and its treatments. This is especially true for the novel coronavirus, SARS-CoV-
2. People with cancer are twice as likely to die from COVID-19 compared to the general
population, with some subgroups appearing to fare much worse. The pandemic has also led to
significant disruption in cancer screening, diagnosis, and treatment, which is anticipated to lead
to an indirect increase in morbidity and mortality in this population. Thus, studying COVID-19 in
people with cancer is highly warranted. In this U01 project, “The COVID-19 and Cancer
Consortium (CCC19) Registry”, we leverage the established CCC19 registry (NCT04354701),
which is the largest registry of adults with COVID-19 and cancer in North America, to answer a
number of important scientific questions. In Aim 1, we evaluate how anticancer treatments, anti-
COVID-19 treatments, vaccination, and, importantly, their interactions modify short- and long-
term complications. We will explore whether race, ethnicity, and sociodemographic factors (e.g.,
insurance, access to treatment) are associated with outcomes. We will explore whether data-
driven feature selection with machine-learning algorithms reveals unrecognized associations. In
Aim 2, we hypothesize that there will be measurable changes in cancer recurrence and
progression in patients who survive COVID-19. We will also investigate whether anticancer
treatment modifications, which we have observed in 40% of patients who were on anticancer
therapy at the time of infection, will affect longer-term prognosis. In Aim 3, we will develop
methods to measure ascertainment and collider biases, which are some of the most important
sources of bias in registry-based study designs. Along with these aims, we will continue to support
and maintain the CCC19 registry and promote its use by the general community, following the
FAIR principles.

Public health relevance
Project Narrative People with cancer are vulnerable to SARS-CoV-2 infection and often experience severe outcomes of the resultant COVID-19. We have gathered more than 17,000 case reports of people with cancer and COVID-19 through the COVID-19 and Cancer Consortium registry. This project will lead to a greater understanding of outcomes in these patients, in particular cancer- related outcomes that may not be evident until years after the primary infection.